Virology Core

VIROLOGY CORE - ABSTRACT
The goal of the Virology Core at UTMB-Novartis Alliance for Pandemic Preparedness is to support the delivery
of the proposed clinical candidates by pursuing three aims. Aim 1. In vitro evaluation of inhibitors. The Virology
Core will evaluate in vitro activities of compounds by pursuing two sub-aims. (i) Preparation of reporter virus
stocks for high-throughput library screen. (ii) Antiviral spectrum analysis of hits or leads. Aim 2. Mode-of-action
and drug resistance studies. The Virology Core will pursue mode-of-action and drug resistance studies through
three sub-aims. (i) Target deconvolution. (ii) Resistance analysis of inhibitors of known viral targets. (iii) Fitness
analysis of resistant virus. Aim 3. In vivo evaluation of inhibitors. We will evaluate the in vivo efficacy of inhibitors
in animal models through three activities. (i) Three treatment timelines will be performed based on the start of
compound treatment: pre-infection treatment (prophylactic), immediate treatment after infection, and post-
exposure treatment. (ii) Treatment with different doses will also be performed to establish dose responses.
Pharmacokinetics and pharmacodynamics will be established for the inhibitors. (iii) Combination therapy will be
performed to determine additive, synergistic, or antagonistic effect of two different types of inhibitors to overcome
resistance.